Multiplex Imaging of Brain Activity and Plasticity with Optimized FRET/FLIM-based Sensors

Project Summary
Plasticity is a fundamental aspect of neuronal circuits across all species. It is at the base of
learning and memory, sensory adaption, and many disease-related processes such as addiction,
chronic pain or regeneration. On the molecular level biochemical mechanisms have been well
described, but little is known on how these are coordinated in space and time within neuronal
circuits of living brains. To elucidate the circuit operation of plasticity in vivo we here propose to
develop and validate highly sensitive, red FRET/FLIM sensors for simultaneous use with green
calcium sensors, allowing imaging of neuronal calcium activity and biochemical signaling
dynamics in individual synapses and neuronal populations. We will focus on plasticity-linked
biochemical events involved in synaptic plasticity and spine morphogenesis. FRET/FLIM sensors
will allow for the accurate measurement of small changes, even in the presence of brain
movement during behavior. In aim 1, we will develop highly sensitive red-emitting FRET/FLIM
sensors using mammalian cell based protein libraries and structurally-guided large scale
screening. Aim 2 will involve validation of sensors ex vivo and in vivo. Finally, sensors will be
validated for use in studies on synaptic and neuronal plasticity during spatial navigation tasks in
awake mice. We plan for iterative cycles of improvements in which input from biophysical analysis
of sensors, validation in slices and in vivo and feed-back from early roll-out users with different
animal models will be used to create successive sensor generations with ever increasing
performance. Combined in vivo 2P FRET/FLIM of plasticity and 2P fluorescence imaging of
calcium activity will provide a powerful new approach to study synaptic and neuronal plasticity in
living organisms.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will optimize a powerful set of genetic tools to monitor with high spatiotemporal resolution the biochemistry linked to neuronal plasticity in the brain. This will enable new studies into basic mechanisms in learning and memory, sensory adaption and investigations into disease-related questions involving recovery from injury, addiction and chronic pain.